Understanding the sequence and structural determinants of phase behavior of ALS-causing proteins

Summary
Amyotrophic lateral sclerosis (ALS) is a life-threatening, neurodegenerative disease that causes the
degeneration of motor neurons in the brain and spinal cord. There are currently neither a cure nor effective
treatments to slow progression. However, recent new genetic, biochemical and biophysical evidence implicates
stress granules as crucibles for disease development. Stress granules are membraneless organelles, also called
biomolecular condensates, which form via liquid-liquid phase separation (LLPS) of RNA-binding proteins and
RNA. Mutations in RNA-binding proteins convert liquid-like stress granules into solid inclusions. Prolonged stress
granule assembly can result in similar effects. These observations point to new opportunities for therapeutic
interventions if key open questions regarding the nature of liquid vs. solid assemblies can be answered. We will
thus test the overarching hypothesis, which is based on above observations, that mutations in RNA-binding
proteins change the driving forces for phase separation, the dynamical arrest of the liquid condensates and the
ability of the condensates to promote the formation of protein fibrils. Our proposed studies will thus focus on the
physics of phase separation of RNA-binding proteins, specifically on their intrinsically disordered low-complexity
domains (LCDs) that are sufficient for mediating phase separation and are the typical locations of disease
mutations. We will use the LCD of hnRNPA1 as an archetypal member of the class of ALS-associated RNA-
binding proteins and will extend our studies also to the LCD of FUS. Mittag and Pappu have recently developed
a stickers-and-spacers model that is based on the identification of transient, cohesive interactions amongst
aromatic amino acid residues as providing the main driving force for phase separation. The aromatic residues
are the stickers in this model, the spacers are the residues that connect the stickers. The model enables the
quantitative prediction of full coexistence curves as a function of temperature and, importantly, resulted in a
conceptual advancement of our understanding of how phase separation is encoded in LCDs. The complimentary
expertise of Mittag and Pappu will now bring to bear a combination of biophysical experiments, computation and
theory on the following three specific aims: (1) To extend the stickers-and-spacers model by quantifying the
interplay among different types of stickers and spacers. (2) To test the hypothesis that disease causing mutations
within LCDs of ALS-causing RNA-binding proteins cause dynamically arrested phase transitions. (3) To uncover
the interplay among sidechain and backbone interactions and their contributions to spatial organization of LCDs
within dense phases. Our results will enable quantitative predictions of the effects of ALS-associated mutants
on phase behavior. We will obtain a clear understanding of how sequence-specific phase diagrams contribute
to the dynamics of phase separation and aging phenomena. We will identify the types of interactions underlying
liquid-like and solid-like dense phases. These results will have a direct bearing on therapeutic interventions
against the functional disruptions that are likely to be caused by dynamically arrested phase separation.

Public health relevance
Narrative Amyotrophic lateral sclerosis is a devastating neurodegenerative disease without cures. Recent progress has revealed stress granules as the cellular locales of the formation of protein aggregates and disease development, renewing efforts to understand the molecular basis of pathogenesis. We will use biophysical experiments, simulations and theory to understand the physical principles underlying the formation of protein aggregates in stress granules overcoming critical bottlenecks for combatting the disease.